Administrative Core

Administrative Core Abstract
The overall aim of the Administrative Core (AC) of this Program Project, entitled the Brown University Alcohol
Research Center on HIV (ARCH), is to provide the scientific, administrative, and financial support needed to
conduct the best possible science on evaluating and implementing interventions to reduce alcohol misuse
among those living with HIV and those at high risk for HIV. The AC will build upon lessons learned and
successful practices developed and refined over the past two segments of ARCH funding. The AC has
overseen the evolution of the ARCH from a broad focus on biobehavioral interactions between alcohol use and
HIV to a more defined purpose of implementing alcohol interventions in real-world settings where our impact
on HIV prevention and care can be greatest. The ARCH contains 5 integrated parts that make unique
contributions to our interdisciplinary approach: three Research Components (RC), a Research Methods Core,
and this AC, which oversees coordination of the projects, training of postdocs, and funding of promising pilot
projects. Under the direction of Program Director Christopher Kahler and Deputy Director Peter Monti, the aims
of the AC are: (1)To provide organizational structure for effective scientific leadership; (2) To provide general
administrative, fiscal and logistical management of daily operations, assure the smooth functioning of the
scientific work, and maintain sound policies/procedures; (3) To obtain external oversight from a Program
Advisory Committee, seek Committee advice for major decisions/strategic direction and evaluation of pilot
projects, and arrange timely presentations to the Committee; (4) To ensure appropriate allocation to and
tracking of use of core resources by RCs and Pilot Projects; (5) To provide and monitor a training/mentoring
plan for all ARCH-affiliated postdocs; (6) To provide for and monitor a pilot project program that will fund four
pilot projects, one of which is proposed herein; (7) To ensure collaboration and communication among ARCH
and collaborating investigators, both within and outside of Brown; (8) To coordinate new extramural grant
submissions consistent with the Project’s mission; (9) To increase local, regional, national and international
visibility of this ARCH, attract outside scientists to become active participants, and foster new collaborative and
interdisciplinary relationships. The AC enhances the RCs by allowing more comprehensive, ambitious, and
innovative alcohol/HIV intervention projects to be conducted with high cost efficiency and greater coordination
of research methods and implementation frameworks. Further, the AC will serve as the nexus for training and
integration of alcohol/HIV science across RCs, pilot projects, and complementary studies, so as to yield new
insights into the implementation of interventions to reduce alcohol misuse in HIV prevention and care settings.